Impact Of Familiarity And Attachment On Visual Processin

The neural circuitry involved in processing the visual stimulus of a human face has received considerable research attention, with evidence indicating that some brain regions may respond preferentially to such stimuli. However, we know little about how neural processing is affected by the subject's familiarity with, or emotional attachment to, the person whose face is depicted. Research in this area could form a bridge between cognitive neuroscience and the newly emerging field of affective neuroscience by indicating pathway(s) linking limbic and sensory circuits. In addition, the use of emotionally significant faces as activation stimuli may help to elucidate the neural circuitry underlying interpersonal attachment and psychological responses to loss. Thus, this functional magnetic resonance imaging protocol uses a face recognition activation task to examine how neural processing varies depending on whether the face depicted is emotionally significant to the viewer. In a series of studies, subjects view unfamiliar and familiar (including personally familiar and famous) faces; mothers view pictures of their own child and those of familiar and unfamiliar children; and bereaved and non-bereaved spouses view pictures of their spouse, other family members, and unfamiliar people. To date, ten subjects have completed the study that uses personally familiar, famous familiar, and unfamiliar faces as stimuli, and ten mothers have completed the second study. Preliminary results from the “celebrities” and “mothers” studies indicate that the activity in several areas is modulated by the emotional/social valence of familiar individuals. Familiarity modulated activity in the fusiform gyrus, where unfamiliar faces evoked a higher response than did familiar faces. Within the pool of familiar faces, however, faces of individuals with stronger personal emotional attachment evoked stronger responses in this area. For example, relatives and friends evoked a stronger response than did famous familiar faces, and seeing one’s own child evoked a stronger response than did seeing the face of a familiar but unrelated child. A differential response to different categories of stimuli also was detected in the amygdala, with a decrease in the activity for personally familiar faces compared to familiar famous faces and the faces of strangers. By contrast, higher activity was detected in the left amygdala when mothers looked at the pictures of their own child as compared to looking at a familiar, unrelated child.